Circadian Clock and Myc-dependent Regulation of Cellular Transformation

PROJECT SUMMARY/ ABSTRACT
Colorectal cancer (CRC) is the third most diagnosed cancer in the United States. Though CRC cases in adults
(55 and older) have decreased, the incidence of CRC in young adults, ages 15-40, is on an alarming rise. It is
estimated that by the year 2030, a staggering 11-12% increase in early-onset (EO) cancers will be observed.
Adult cases of CRC typically harbor driver mutations in Apc, a tumor suppressor that regulates Wnt signaling, in
addition to second hits in Kras, Braf, p53 and Smad4. Apc mutations are also found in early-onset CRC (EO-
CRC), but a decrease in the typical second hit driver pathways has been reported. Therefore, there is an urgent
need to better define the root cause of EO-CRC. Moreover, clinical evidence suggests that diet is likely a root
underlying cause of the increased incidence in sporadic cases of EO-CRC. Interestingly, dietary challenge and
timing of food intake directly impinge on the circadian clock, which is our internal pacemaker that governs
sleep/wake cycles, feeding, hormonal and other cyclic rhythms. This suggests that disruption of the circadian
clock could be a major risk factor for EO cancers. In further support of this idea, clinical data indicates that clock
genes are broadly downregulated in human colorectal tumors, suggesting that suppression of the clock could be
important for transformation in the intestinal epithelium. To directly address the potential links between the clock
and CRC, we have developed a novel genetic mouse model to define how disruption of the circadian clock drives
CRC pathogenesis. Our preliminary data demonstrates that disruption of the clock in the intestinal epithelium
drives a statistically significant increase in polyp formation. Using our mouse model system, organoid cultures
reveal that clock disruption accelerates transformation in the intestinal epithelium. Based on these findings, we
hypothesize that clock disruption impinges on intestinal transformation and rewires cellular metabolism to sustain
the heightened demand of hyperproliferative cells. Aim 1 will define how the clock machinery regulates genome
instability and transformation in the intestine. Aim 2 will determine the role of the circadian clock in governing
metabolism of intestinal epithelial cells in both mouse and human organoid systems, established from EO-CRC
patient samples. Aim 3 will delineate how dietary paradigms that disrupt the circadian clock accelerate intestinal
transformation. The broader impact of our findings will outline new prevention strategies for eradicating EO-CRC
and other cancers that potentially relate to disruption of the circadian clock. Additionally, our long-term goal is to
achieve targeted pharmacological approaches to regulate the circadian clock and therefore minimize behavioral
and lifestyle factors that potentially impinge on tumorigenesis.

Public health relevance
PROJECT NARRATIVE This proposal is aimed at defining how disruption of the circadian clock, both genetic and environmental, accelerates colorectal cancer pathogenesis using mouse models and patient-derived intestinal organoids. We propose that the circadian clock regulates signaling and proliferation pathways as well as rewired metabolism to drive transformation of the intestinal epithelium. Our molecular studies will provide new insight towards prevention strategies and targeted therapeutic approaches for the treatment of colorectal cancer that rely on pharmacological modulation of the circadian clock.